Modeling the development, structure and regulation of T cell memory

1SPKFDU 4VNNBSZ *NNVOPMPHJDBM NFNPSZ JT B EFﬁOJOH DIBSBDUFSJTUJD PG WFSUFCSBUF JNNVOF TZTUFNT BOE JT FODPEFE JO QBSU CZ QPQVMBUJPOT PG 5 MZNQIPDZUFT UIBU SFTQPOE SBQJEMZ BOE QPUFOUMZ UP SFQFBU FYQPTVSFT UP QBUIPHFOT ?FTF QPQVMBUJPOT BSF SFNBSLBCMZ EJWFSTF JO UIFJS QIFOPUZQFT BOE USBﬃDLJOH QBUUFSOT BOE DPMMFDUJWFMZ GPSN BO FDPTZTUFN UIBU SFﬂFDUT B MJGFUJNFT FYQPTVSF UP QBUIPHFOT BOE UP PVS FOWJSPONFOU :FU B GVOEBNFOUBM BOE QSFTTJOH QSPCMFN SFNBJOT o XF IBWF B WFSZ MJNJUFE RVBOUJUBUJWF HSBTQ PG IPX JNNVOPMPHJDBM NFNPSZ JT FTUBCMJTIFE BOE NBJOUBJOFE IPX OFX NFNPSJFT UP JOGFDUJPOT BSF JOUFHSBUFE XJUI FYJTUJOH NFNPSJFT BOE IPX BOE XIZ UIFTF XBOF PWFS UJNF EFUBJMFE VOEFSTUBOEJOH PG UIFTF QIFOPNFOB XPVME HVJEF UIF EFTJHO PG WBDDJOFT UIBU JOEVDF EVSBCMF JNNVOJUZ BOE UIF EFWFMPQNFOU PG UIFSBQJFT UP SFWJWF BOE TVTUBJO 5 DFMM SFTQPOTFT JO UIF TFUUJOHT PG DISPOJD JOGFDUJPOT BOE DBODFS ?F NFNPSZ FODPEFE CZ DJSDVMBUJOH 5 DFMMT JT IJHIMZ EZOBNJD *U JT TDVMQUFE CZ TFMGSFOFXBM EJﬀFSFOUJBUJPO MPTT BOE TVQQMFNFOUBUJPO PS DPNQFUJUJPO XJUI OFXMZSFDSVJUFE DFMMT 'VSUIFS JO CPUI NJDF BOE IVNBOT NFNPSZ JOEVDFE CZ QBUIPHFOT DPFYJTUT XJUI BCVOEBOU AOBUVSBM NFNPSZ 5 DFMMT XIJDI BSF TQFDJﬁD GPS DPN NFOTBM BOE FOWJSPONFOUBM BOUJHFOT CVU QSPWJEF DSPTTQSPUFDUJPO UP OFX JOGFDUJPOT BOE XJUI SFHVMBUPSZ 5 DFMMT UIBU MJNJU JOBQQSPQSJBUF SFTQPOTFT 8F IBWF WFSZ MJUUMF VOEFSTUBOEJOH PG IPX UIFTF UISFF QPQVMBUJPOT SFMBUF *O UIJT QSPKFDU XF XJMM JOUFHSBUF UPHFUIFS B QPXFSGVM TFU PG NPEFMJOH BOE FYQFSJNFOUBM BQQSPBDIFT UP DPO GSPOU UIFTF VODFSUBJOUJFT 4QFDJﬁDBMMZ XF XJMM EFWFMPQ B TUSVDUVSFE QPQVMBUJPO NPEFMJOH 1%& BQQSPBDI UP VTF XJUI B GBUFNBQQJOH TZTUFN UIBU USBDLT 5 DFMM QPQVMBUJPOT UISPVHIPVU UIFJS MJGFIJTUPSJFT 8F XJMM UIFO DPNCJOF UIF GBUF NBQQJOH TZTUFN XJUI B %/ MBCFMJOH NFUIPE BOE 0%& NPEFMT UP EFﬁOF NFNPSZ 5 DFMM EZ OBNJDT JO EFUBJM 5PHFUIFS UIFTF BQQSPBDIFT XJMM NBQ UIF EFWFMPQNFOU TUSVDUVSF BOE SVMFT PG SFQMBDFNFOU PG DJSDVMBUJOH NFNPSZ 5 DFMM TVCTFUT JO NJDF 8F XJMM BMTP VTF EBUB GSPN B OPWFM EJWJTJPOSFQPSUFS NPVTF TUSBJO UP NPEFM UIF FNFSHFODF BOE MPOHUFSN EZOBNJDT PG 5 DFMM NFNPSZ UP JOﬂVFO[B JOGFDUJPO 'JOBMMZ XF XJMM DPNCJOF NPEFMJOH XJUI GBUFNBQQJOH BOE EJWJTJPOSFQPSUFS NJDF UP VOEFSTUBOE IPX SFHVMBUPSZ 5 DFMMT BSF NBJOUBJOFE BOE IPX UIFZ JNQBDU CPUI OBUVSBM BOE JOﬂVFO[BTQFDJﬁD NFNPSZ QPQVMBUJPOT

Public health relevance
Project Narrative Diverse populations of memory T cells circulate throughout the body and protect us from re-infection by previously encountered pathogens, but our understanding of how these populations develop, compete, and are maintained is incomplete. A quantitative grasp of this complex ecosystem will reveal what determines the duration of T cell memory, and how to manipulate it; for example, to extend the protection given by vaccines, or to boost and sustain the activity of tumor-specific T cells. In this project we will integrate mathematical modeling and new experimental tools to quantify multiple aspects of circulating T cell dynamics in depth.